A Novel Technology to Treat the Underlying Cause of Tinnitus

Project Summary / Abstract
Tinnitus is the pervasive and often debilitating perception of ringing, buzzing, or hissing sounds in the absence
of external stimuli. Sufferers face significant challenges that diminish quality of life, including sleep
disturbances, cognitive difficulties, and reduced productivity. Additionally, the prevalence of mental health
conditions, including anxiety, depression, and somatic symptom disorders, is significantly higher in patients
suffering from tinnitus. Veterans suffering from tinnitus also have a higher likelihood of screening positive for
PTSD. In the United States, up to 50 million people have tinnitus, among whom 20 million are chronic sufferers
actively seeking relief. About 3 million veterans receive tinnitus disability compensation annually making it the
number one service-connected disability for the Department of Veterans Affairs.
Despite the overwhelming need for an effective treatment, today’s options are unsatisfactory to most patients;
20% report receiving no help when visiting their general practitioner for tinnitus, over 66% receive no tinnitus
care or management after being discharged by ear, nose, and throat (ENT) specialists, and 40% of those
discharged return to their general practitioner seeking further help. The major limitation of today’s treatment
options is their failure to address the underlying pathology of tinnitus – dysregulated neural synchrony.
Common treatments such as hearing aids and sound masking devices do not take this into consideration,
instead treating tinnitus as if it were simply an ear disorder. As a result, these treatments can exacerbate
symptoms in some patients.
Auricle’s novel medical device is the first in-home neuromodulatory device that treats the root cause of tinnitus.
Our internationally-patented technology is based on a strong body of peer-reviewed literature. The system
applies auditory stimuli at tinnitus frequencies with precisely timed somatosensory stimuli in the neck or face to
suppress the tinnitus-generating neurons that cause auditory symptoms. Our technology is supported by 33
peer-reviewed publications and has repeatedly been demonstrated to be safe and effective in clinical trials.
Through this SBIR project, the validated technology will be refined for ease-of-ease and scalability, preparing it
for commercialization in order to bring transformative relief to tinnitus sufferers.

Public health relevance
Project Narrative Tinnitus is the pervasive and often debilitating perception of ringing, buzzing, or hissing sounds that results in decreased quality of life and significantly higher rates of mental health conditions such as anxiety, depression, somatic symptom disorders, and – among veterans – PTSD. Available treatment options share the shortcoming of not addressing the underlying causes of tinnitus, which leaves patients unsatisfied and potentially with exacerbated symptoms. We are now refining Auricle’s novel neuromodulatory medical device for in-home treatment of the root cause of tinnitus – which is based on 20+ years of research, 30+ publications, and multiple clinical trials – so it is optimized for market entry.